Measuring Whole and Tissue Level Bone Strength in men

Abstract
Most patients who fracture have non-osteoporotic bone mineral density. Often, the result of a fracture is
devastating and results in substantial morbidity and health care costs. One cause of fragility in these patients is
poor bone quality that subsequently contributes to higher risk for fracture. Yet few techniques are available to
accurately assess bone quality in the clinic. Dual energy x-ray absorptiometry (DXA) is the most used clinical
surrogate for fracture risk, but DXA does not account for bone quality and thus overestimates bone health.
OsteoProbe® Reference Point Indenter enables the measurement of bone quality in human patients and has
been used safely on over 7,000 individuals. The OsteoProbe® quantifies bone material quality as a measure
termed bone material strength index (BMSi). Measurements are made in a routine exam on the midshaft of the
tibia by a safe and rapid microindentation process. A significant and predictive relationship has been
demonstrated between tibial BMSi and fracture occurrence at multiple skeletal sites in published studies and in
our Phase II study. Since fragility fractures occur most often at the hip, wrist, and the spine, this renewal will
allow us to confirm the predictive relationship between OsteoProbe measurements at the tibia and bone strength
at these clinically relevant skeletal sites on male cadavers. As in our original Phase II, we hypothesize that tibial
OsteoProbe® measurements will predict bone strength at the whole bone and tissue levels at the hip, wrist, and
spine for both males and females. At each of these skeletal sites, OsteoProbe measurements, BMD, and whole
bone and tissue level mechanical testing will be performed. The renewal proposal aims to: (1) establish and
confirm the mechanistic basis by which a clinically relevant surrogate of in vivo bone strength could be accurately
measured at the hip, wrist, and spine for males; (2) develop OsteoProbe into a more manufacturable device that
can be produced and supported in volume; and (3) provide pivotal data for an FDA 510(k) approval of a new,
commercially attractive, and reimbursable marketing claim for OsteoProbe.

Public health relevance
Narrative Patients who suffer a fracture but have non-osteoporotic BMD present a unique challenge to physicians since they have no way of identifying these patients before a fracture occurs. OsteoProbe was developed to identify patients at risk of bone fragility through a Phase II SBIR grant, private investment, research, and development. Phase II results demonstrate that OsteoProbe is a strong predictor of skeletal fragility in women. This study will expand on the Phase II work to include males, establish OsteoProbe as a better clinical predictor of bone strength at the hip, wrist, and spine compared to DXA; transition OsteoProbe into an optimized configuration for manufacturing and support in the commercial environment; and provide for a new FDA clearance of OsteoProbe as a clinically useful device aimed at addressing the bone quality diagnostic gap in the general population.